The role of mammarenavirus defective interfering particles in protecting host fitness and the host-driven post-translational modifications that regulate their formation and function

The pivotal discovery of RNA viruses, like the bi-segmented, single-stranded arenavirus family, producing
defective interfering particles (DIPs) over 50 years ago prompted investigations on their contribution to viral
pathogenesis and host immunity. However, many basic questions remain, including the molecular basis for
how DIPs are regulated and the contribution of DIPs to virus–host interactions, including the persistence of
zoonotic pathogens in their reservoir host. Our overall goal is to identify the cellular machinery responsible for
regulating arenavirus DIP production and interrogate the impact DIPs have on reservoir fitness. A major
constraint to understanding the true role of DIPs in viral pathogenesis and disease ecology is the lack of tools
to modulate DIP levels in experimental systems. We recently discovered that LCMV uses divergent cellular
pathways to produce standard virus particles versus DIPs. Using reverse genetic systems, we identified
powerful host-driven post-translational modifications (PTMs) that dynamically regulate the production of
infectious versus defective viral particles. These studies enabled us to engineer, for the first time, recombinant
arenaviruses that no long produce DIPs. Our specific objectives will be to use these innovative approaches
and tools to 1) define the mechanism by which host tyrosine kinases and NEDD4 Family E3 ubiquitin ligases
regulate DIP formation and function, 2) expand our global map of arenavirus PTMs that may influence DIP
production, and 3) connect these molecular findings to pathogenesis studies modeling both persistent infection
of the rodent reservoir and acute infection of the rodent or incidental human host. Most RNA viruses that infect
animals produce DIPs, which suggests they are fundamentally important for the maintenance of these viruses
in nature. Our findings will be broadly applicable beyond the Bunyavirales order. Collectively, the completion of
these studies will provide greater resolution on the regulation of DIP production and answer, for the first time,
the role of DIP in viral persistence.

Public health relevance
Mammarenaviruses often cause severe diseases in humans but establish asymptomatic, lifelong infections in rodent reservoirs. We aim to identify the cellular processes that differentially regulate infectious versus defective particle production and the ecological impact of these defective viral particles on rodent reservoir fitness. This work has the potential to answer long-standing questions regarding for how zoonotic viruses, including those in the Bunyavirales order, are maintained in reservoir species in nature.